Scripps Research Translational Chemical Biology

Project Summary/Abstract
Scripps Research is a leader in the field of chemical biology. This leadership is established on three
core strengths: the high quality of its faculty, its top ranked graduate program, and the excellent
interdisciplinary nature of our research programs. Scripps Research exemplifies itself as a research
institution where ideas in the basic sciences can be seamlessly translated to drug candidates and
clinical trials. Likewise, our institution also boasts the ability to take observations from the clinic and
extract meaningful molecular information from them to innovate on basic principles. Our program is not
bounded by departments, and interdisciplinary work is found in commonplace at Scripps. The overall
mission of our graduate program is to coordinate our established pre-doctoral training program with the
translational drug discovery mission and activities across the Institute. With this Chemical Biology
Training grant, our objective is to train a cadre of elite Scripps Research students with emphasized and
specialized training in translational chemical biology. Under this newly coordinated program, students
will be equipped with advanced chemical biology and translational drug discovery skills that prime them
for successful transition to competitive spots within the biomedical research workforce. These skills will
be developed via our chemical biology didactic curriculum that will be infused with advanced courses
in drug discovery and pharmacology, seminars and trainee presentations, a chemical biology-specific
alumni matching program, an internship program that exposes trainees to local companies that have
been highly successful at translating chemical biology technologies, and a transformative set of career
development activities that are design to teach collaboration as a skill. This training is designed as a
two-year program that commences following the first year of laboratory rotations and the selection of a
graduate advisor who is a member of our molecular-focused 41 Participating Faculty. A projected
number of ten trainee slots will be supported via this program.

Public health relevance
Project Narrative The development of next generation therapeutics that can rise up to the challenge of combatting human diseases depends on a group of individuals that are exquisitely trained to dismantle and manipulate the complexity of biological systems. This proposal requests support in establishing the Scripps Research Translational Chemical Biology Graduate Program to provide specialized training to pre- doctoral students to use chemistry to study or control compelling biological problems towards accelerating the discovery of new therapeutic modalities.